Training in HIV/AIDS Pathogenesis; Basic and Translational Research

This is a renewal application of an institutional HIV/AIDS training program to continue training through years 26
to 30. We plan to train 2 postdoctoral and 4 predoctoral trainees in basic and translational research in HIV/AIDS
pathogenesis topics. Our goal is to produce individuals with high quality training, in topics aligned with the NIH
priorities, and who will be able to enter careers that engage them in national effort to control HIV disease and
its. We have designed a training plan that is in step with the current HIV/AIDS research priorities. We will train
the next generation of HIV/AIDS scientists in four focus groups of research training. These include: (1) HIV
latency persistence and cure; (2) Next generation therapies; (3) Approaches to reducing HIV incidence and (4)
Comorbidities and coinfections. Over the next 5 years, we will (i) Recruit highly qualified pre- and post-doctoral
trainees into the program (where the pre-doctoral trainees will include both PhD and MD/PhD trainees and the
post-doctoral trainees can be either PhD or MD holders); (ii) Provide opportunities for training with mentoring
from outstanding basic and translational HIV/AIDS researchers at Einstein using modern, cutting edge research
facilities; (iii) Provide monitoring, evaluation and advice by internal and external senior HIV/AIDS scientists; (iv)
Provide a platform of regular work-in-progress meetings attended by a community of translational HIV/AIDS
mentors, all current and previous T32-supported trainees in residence and other trainees of the participating
trainers on a regular basis and (v) provide opportunities for career guidance for both traditional research careers
(including grantsmanship mentoring) and non-traditional careers. The 15 faculty trainers on this training grant
each work on national priority areas of HIV/AIDS research, engage in highly collaborative interdisciplinary
research, are all funded (bringing in over 26 million dollars of federal funds to Einstein this year) and participate
in a unique training program that collaborates with the Department of Microbiology and Immunology, Einstein-
Montefiore Center for AIDS Research (CFAR), the MACS-WIHS Combined Clinical Cohort (MWCCS), the
NIGMS-supported Cell and Molecular Biology and Genetics (CMBG) training program aimed at maximizing
training opportunities for our trainees. The presence of highly relevant centers and programs, program projects
focused on microbicides or pre-exposure prophylaxis (PREP) products, robustly-funded trainers and the superb
research facilities, together create an exciting environment for training pre- and postdoctoral trainees in HIV/AIDS
research at Einstein. This training program, as outlined in this application, plays a catalytic role to seamlessly
bring together multiple opportunities for trainees in the context of our training program. This training program
thus provides a comprehensive and coordinated platform for training of pre- and postdoctoral trainees in
translational AIDS research at Einstein.

Public health relevance
Project Narrative Although highly effective anti-HIV drugs are available and are making an impact on HIV control, HIV epidemic is still a major health problem. This long-standing training program is dedicated to training individuals who wish to secure their PhD or M.D./PhD dual degrees in HIV/AIDS Research and to offer advanced training in specialized HIV/AIDS topics to those who have already obtained a PhD Or MD degrees. An outstanding roster of training faculty and research topics that are aligned with national priorities assure a high quality, targeted training of individuals who will form the future workforce that tackles the AIDS epidemic in the coming years.